Animal model of HLA-B27 disease

Abstract
The spondyloarthropathies (SpAs) are human diseases, characterized by sacroiliitis and overlapping clinical
features, of unknown pathogenesis. The prototypical SpA, ankylosing spondylitis (AS), is one of the best known
and strongest examples of a disease associated with an HLA allele, specifically HLA-B27, an association known
for 50 years. Since HLA-B27 is a major histocompatibility complex class I (MHC-I) molecule, it seems likely
that it is involved in disease pathogenesis by presenting peptide antigens on antigen-presenting cells (APCs) to
CD8+ T cells, the canonical function of MHC-I molecules. However, due to lack of direct support of this
hypothesis, and conflicting data from previous HLA-B27 rodent models, other hypotheses became more
favored, even though genome-wide association studies and lack of association of AS with certain HLA-B27
alleles that affect peptide display support a role for HLA-B27 in antigen presentation in disease. Recent studies
from the applicant’s laboratory in collaboration with an international group showed clonal expansion of certain
T cell receptors (TCRs) on CD8+ T cells in the joints of patients with AS and eye of patients with anterior
uveitis, a frequent complication of the SpAs, that can occur in isolation and is also associated with HLA-B27.
These TCRs were used to identify peptides from bacterial and human proteins that are presented by HLA-B27
to trigger TCR reporter cells. Importantly, several of these TCRs recognized both bacterial and self-peptides
presented by HLA-B27. Crystallographic studies showed the basis for this TCR cross-reactivity. These studies
strongly suggest the overall hypothesis to explain the pathogenesis of AS, the basis for this proposal: Antigen-
specific CD8+ T cells in HLA-B27+ individuals clonally expand in response to bacterial challenge then attack
normal tissues expressing the cross-reactive self-protein(s). To test this model, the applicant proposes here to
create a mouse expressing a relevant TCR and HLA-B27 for such mechanistic immune response studies that
are otherwise impossible to pursue in humans. To avoid other technical and knowledge limitations of prior
HLA-B27 rodent models, they will produce other modifications. Therefore, the Specific Aims of this proposal
are to: 1) Generate HLA-B27 mouse models; and 2) Perform functional analyses of T cells and APCs in HLA-
B27 mice. Thus, this proposal will lead to the development of a mouse model for detailed mechanistic studies
to further explore the pathogenesis of HLA-B27 in AS and related diseases, and indeed lay the foundation for
mechanistic studies of other HLA-associated autoimmune disorders.

Public health relevance
Project Narrative This project plans to study the pathogenesis of human diseases that are associated with HLA-B27, such as ankylosing spondylitis and anterior uveitis. Based on newly published information, they hypothesize that CD8+ T cells respond to bacterial challenges which then result in their attack of normal tissues due to cross-reactivity. Such detailed studies will require the development of a mouse model. Here the investigator presents plans to develop such a model by producing mice expressing the relevant human molecules that include HLA-B27, a relevant T cell receptor and other molecules required for optimal T cell responses.